The impact of inflammation induced alterations to microbially derived bile acids on susceptibility and severity of Clostridioides difficile infection

PROJECT SUMMARY/ABSTRACT
Patients with inflammatory bowel disease (IBD) are four times more likely to acquire Clostridioides difficile
infection (CDI), and experience higher mortality and excessive complications compared to the general
population. The mechanism by which IBD confers susceptibility to CDI is unknown, making it impossible to
implement preventative measures for IBD patients. The long-term goal is to investigate how interactions between
the gut microbiota and host contribute to colonization resistance against enteric pathogens in complex diseases
such as IBD. The overall objective of this application is to define the role of the gut microbiota and the microbially
derived secondary bile acids (SBAs) in conferring susceptibility and contributing to the severity of CDI during
intestinal inflammation caused by IBD. The central hypothesis is that inflammation-induced alterations in the gut
microbiota lead to a decrease in SBAs resulting in loss of colonization resistance against C. difficile thus
exacerbating this infection in IBD patients. Guided by preliminary data, this hypothesis will be tested by pursing
two specific aims: 1. Determine if supplementation with the exogenous secondary bile acid ursodeoxycholic acid
(UDCA) alters susceptibility and disease severity during CDI in IBD; and 2. Determine if modulation of intestinal
microbiota derived bile acid composition alters susceptibility and disease severity during CDI in IBD. For Aim 1,
IL10-/- colitis mice administered daily UDCA will be challenged with C. difficile. Inflammation-induced alterations
in the gut microbiome, bile acid metagenome and metabolome, and host response during CDI will be defined.
For Aim 2, precision gut microbiota modulation will be used to compare inflammation-induced (IL10-/- colitis) CDI
susceptibility and severity in microbial ecosystems capable of synthesizing SBAs to ones that cannot. This
approach is innovative because it utilizes intestinal inflammation as the sole initiator of gut microbiota and bile
acid alterations to confer susceptibility to CDI. This contribution is significant because it will lead to novel non-
antibiotic therapeutic and preventative interventions for IBD patients with CDI aimed at reducing morbidity,
mortality, and health care costs for this patient demographic. Deciphering interactions between the gut
microbiota, microbially derived SBAs, and the host may elucidate how intestinal inflammation confers
susceptibility to CDI. Finally, this proposal will advance my training in shotgun metagenomics, integration of
bioinformatics, murine IBD models, and rational manipulation of the gut microbiota and bile acid metabolome
into hypothesis driven research. This will support my transition into an independent clinician scientist in
translational and interdisciplinary infectious disease research. This work will be completed at the Ohio State
University College of Veterinary Medicine under the guidance of my mentoring team with globally recognized
expertise in the fields of metagenomics, bioinformatics, rational gut microbiota manipulation, host-microbe
interactions, and IBD pathogenesis.

Public health relevance
PROJECT NARRATIVE Despite increasing incidence of Clostridioides difficile infection (CDI) in inflammatory bowel disease (IBD) patients, the mechanism by which IBD confers susceptibility is unknown. The aim of this proposal is to define the role of the gut microbiota and the microbially derived secondary bile acids in conferring susceptibility and contributing to the severity of C. difficile infection during intestinal inflammation caused by IBD. The work in this proposal will directly impact public health through the development of novel non-antibiotic therapeutic and preventative interventions aimed at substantially reducing morbidity, mortality, and health care costs for IBD patients with CDI.